DAVID MCKAY PRT TIME

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. We are continuing our studies on the structures and mechanisms of molecular chaperone proteins which, broadly speaking, facilitate the correct folding, assembly and targeting of proteins and RNA molecules in cells. Systems that are currently under study include a "prokaryotic proteasome", a 850 kDa complex that is a simple homolog of the eukaryotic proteasome;a family of "stress endurance" factors called universal stress proteins;a chaperone that facilitates folding and assembly of membrane proteins in bacteria;and a family of RNA chaperones/helicases that modulate RNA structure in cells. Additionally, we are continuing our studies on the structure and mechanism of small catalytic RNAs, or ribozymes.